Selective inhibition of COPZ1 in PDAC cells

Project Summary
The common approaches in cancer treatment involve drugs that act on DNA or proteins involved in cell
proliferation. Regrettably, such drugs are (a) not selective to tumor cells causing damage in normal cells, and
(b) ineffective in killing nondividing tumor cells, which can cause tumor relapse after the initial remission, leading
to therapy failure. In our search for a protein that can kill tumor cells regardless of theirs proliferating status, we
noted that the Protein Complex of Secretory Vesicle I (COPI) is involved in retrograde transport of proteins in
the ER-Golgi secretory pathway, endosome maturation, and autophagy homeostasis. Its depletion leads to
abortive autophagy, ER stress, unfolded protein response (UPR), and apoptosis. Almost all of the COPI
components are expressed at the same levels in both normal and tumor cells. However, the coatomer protein
complex I subunit 2 (COPZ2) is drastically downregulated in the tumor cells. Interestingly, in normal cells, the
inhibition of the coatomer protein complex subunit 1 (COPZ1, an isoform of COPZ2) does not affect COPI
function. However, the silencing of COPZ1 and COPZ2 simultaneously led to the loss of COPI function and,
consequently, cell death. Then, COPZ2 deficiency indicates tumor cells' dependency on COPZ1. Therefore,
selective COPZ1 inhibition in COPZ2-deficient tumor cells can potentially overcome the therapy failure problem.
We will design a promising lead compound to inhibit COPZ1 in COPZ2-deficient tumor cells, selectively killing
tumor cells over healthy cells. Our first-generation synthesized COPZ1 inhibitors (based on virtual screening)
showed good selectivity against PDAC. Our central objective is to develop the second-generation small-
molecule-based COPZ1 inhibitors that can kill PDAC cells selectively over normal cells by merging molecular
modeling, chemical Synthesis, cellular mechanistic studies, and animal experiments. Specifically, we will
improve COPZ1 selectivity by conjugating small organic molecules to interact with a secondary binding site. We
hypothesize that the tumor cell death induced by selective inhibition of COPZ1 could lead the proliferating and
nondividing tumor cells to apoptosis but not normal cells.

Public health relevance
Project Narrative: Regardless of all efforts to develop new technologies and treatments, the 5-year survival rate for PDAC remains low. Although crucial for current cancer therapy, the conventional anticancer drugs used to kill tumor cells and damage healthy cells, wreaking havoc on the rest of the body, decreasing treatment efficacy, and favoring de novo carcinogenesis. Especially in hard-to-treat cancers such as pancreatic ductal adenocarcinoma (PDAC), the limitation of the current treatments leads patients to believe, at present, that surgical resection is the only potential cure. Regrettably, only 15-20% of the cases are resectable, the recurrence rate is still high, and the unavoidable rates of long-term survival are dismal. As a solution for the lack of possibilities to increase patients' survival rate, health, and cure during conventional therapy, we propose a new approach to cancer treatment that will selectively kill tumor cells in any proliferative stage with the potential to eradicate the tumor.